Integrative approaches to dissection of endocrine communication

Project Summary/Abstract
Mechanisms of inter-organ signaling have been established as hallmarks of nearly every
pathophysiologic condition, where many exist as related and complex diseases. While significant work has
been focused on understanding how individual cell types contribute and respond to specific perturbations
related to common, complex disease, an equally-important but relatively less-explored question involves how
relationships between organs are altered in the context of an integrated living organism. Current technical
advances, such as proteomic analysis of plasma or conditioned media, have allowed for a more unbiased
visualization and discovery of additional inter-tissue signaling molecules. However, one important feature
which is lacking from these approaches is the ability to gain insight as to the function, mechanisms of action
and target tissue(s) of relevant molecules. To begin to address these constraints, we initially developed a
correlation-based bioinformatics framework which uses multi-tissue gene expression and/or proteomic data, as
well as publicly available resources to statistically rank and functionally annotate endocrine proteins involved in
tissue cross-talk. Using this approach, we identified many known and experimentally validated several novel
inter-tissue circuits. This was this first study to directly link an endocrine-focused bioinformatics pipeline from
population data directly to experimentally-validated mechanisms of inter-tissue communication. While these
validations provide strong support for exploiting natural variation to discover new modes of communication,
these serve as simple proof-of-principle studies and, thus has promising potential for expansion. As a result,
we have developed a series of in silico tools to guide discovery of endocrine interactions. Specifically,
pathway-targeted enrichments, Bayesian network interrogation and scalable machine learning. The goal of
this proposal is to closely bridge these computational tools with experimental methods to systematically dissect
mechanisms by which tissues communicate and how these interactions are perturbed in metabolic disease
settings. Given that we survey genetic variation to guide prediction of new modes of endocrine
communication, these findings are likely to be robust across diverse backgrounds. We will implement high-
throughput screening of specific tissue communication circuits which operate under disease-specific conditions
of metabolism (ex. Obesity and Type 2 Diabetes), define which are conserved from mice to humans and
mechanistically dissect pathophysiologic impacts of endocrine communication through in vivo experimentation.
The success of these aims relies heavily on bridging computational and experimental approaches, justified by
the training and focus of the PI. Collectively, these objectives will begin with unbiased computational
approaches, validate using high-throughput in vitro assays and evaluate therapeutic potential of new endocrine
interactions using mouse models of disease.

Public health relevance
Project Narrative Endocrine interactions have been demonstrated as causal and contributory to most common, most notably obesity, type 2 diabetes and resulting cardiovascular complications. The goal of this proposal is to closely bridge computational and experimental methods to systematically dissect mechanisms by which tissues communicate and how these interactions are perturbed in disease settings. Collectively, we will begin with newly developed and unbiased computational approaches which survey population data, validate using high-throughput in vitro assays and evaluate therapeutic potential of new endocrine interactions using mouse models of metabolic disease.